Core A: Administrative Core

PROJECT SUMMARY (See Instructions): The Administrative Core will provide administrative oversight of the entire Program Project. This will include not only budgetary and scientific oversight and coordination of individual Projects and the Behavioral Core, but also organization of meetings and interactions with the Scientific Advisory Committee [Drs. Kent Bemdge (University of Michigan), Regina Carelli (University of North Carolina) and Ron See (Medical University of South Carolina)], and coordination with our Statistical Advisor, Dr. Ed Rothman (University of Michigan).

Public health relevance
RELEVANCE (See instructions): Addiction is a major public health problem in the United States. The goal of this Project is to use a preclinical model to delineate the psychological and neurobiological basis of individual differences in vulnerabilty to develop addiction-like behavior, as this will help identify risk factors that will aid in the development of targeting interventions and treatments.